Individualized Care for At Risk Older Adults

Assuring that all older adults coping with complex care needs at home have access to high-quality health and
social services and providing essential support to their caregivers are significant and growing societal challenges.
Effective responses to these priorities require research-informed solutions, especially those designed to reduce
systemic and structural inequities that disproportionately threaten the capacity of many older adults to remain at
home. The recent “hospital at home” movement is further fueling the demand for science-based care models
that address health needs and preferences, mitigate the impact of adverse social determinants of health, and
support caregivers, especially throughout challenging health transitions (e.g., new diagnosis, change in
functional status) and health care transitions (i.e., movement across health care providers or settings). The 12
core faculty responsible for the proposed renewal of the NINR-funded Individualized Care for At-Risk Older
Adults—a T32 training program based at the NewCourtland Center for Transitions and Health at the University
of Pennsylvania School of Nursing—are uniquely positioned to prepare four predoctoral and two postdoctoral
nurse trainees, appointed annually, to conduct transdisciplinary research designed to address these societal
priorities. Guided by both the National Institute on Minority Health and Health Disparities’ Research Framework
and the Agency for Healthcare Research and Quality’s Multiple Chronic Conditions Research Network
conceptual model, and with a focus on the transitional care needs of at-risk older adults living at home and those
of their caregivers, trainees will be positioned to conceptualize, design, and conduct research aimed at advancing
integrated care models that promote health equity. Trainees will gain the theoretical knowledge and
methodological skills necessary to conduct rigorous and reproducible research guided by the highest ethical
standards, within a team science framework; employ contemporary and emerging research designs and
methodologies; and promote knowledge synthesis, dissemination, and implementation, with the ultimate goal of
conducting science that informs health care practices and policies and highlights nurses’ unique contributions.
The proposed training program benefits from considerable faculty expertise in aging, health equity, transitional
care, ethics, home and community-based care, and research methods. Led by two prominent nurse scientists,
the program has evolved to foster breadth and depth of conceptual and empirical knowledge related to health
inequities and integrated care models for diverse groups of older adults and their caregivers. Enhanced training
in research methods will emphasize sophisticated data science, emerging mixed methods designs, and multi-
level interventions with enhanced translational potential. Since 2007, this T32 has prepared 23 predoctoral
fellows and 24 postdoctoral fellows who are successfully pursuing scholarly careers focused on advancing
effective health and health care transitions of at-risk older adults. We expect our next cohorts to make substantive
contributions to advance high-quality care and support caregivers.

Public health relevance
Addressing the needs of the growing population of older adults who are coping with complex health and social challenges and supporting their family caregivers are significant societal priorities. Building on our success since 2007, we will continue to prepare nurse scientists to advance science that seeks to develop and improve integrated care models, mitigate adverse social determinants of health, and equitably support older adults and caregivers throughout transitions in health (e.g., new diagnosis, illness progression) and health care (i.e., movement across health care providers or settings). Our faculty mentors will contribute rich scientific expertise, resources, and networks to provide an excellent foundation and environment for this training program.